Population Dynamics in Africa: Selected Outcomes and Causes

ABSTRACT This project will provide new insight into climate-induced migration in Sub-Saharan Africa with a focus on how this process varies over space and how destination areas are affected. To address these issues, we will link individual-level data on internal migration and employment from eight countries to area-level data on climate anomalies, vegetation greenness, and nighttime anomalies. This will first allow a fixed-effects analysis of how individual-level and area-level characteristics modify the climate-migration relationship. We hypothesize that areas with low population density, low lifetime migration networks, low educational attainment and hot/dry climates are more likely to experience climate-induced immobilization, or “trapped populations”. Secondly, we will use an instrumental variables approach to analyze how climate-induced migration affects individual employment, area-level vegetation greenness, and area-level nighttime luminosity. We hypothesize that receiving climate-induced migrants will reduce employment of non-migrants, reduce vegetation greenness, and increase nighttime luminosity. These results will substantially broaden the global knowledge base on climate- induced migration, which currently provides little insight into which areas are likely to vulnerable to displacement and immobilization, as well as whether destination areas are likely to experience negative social consequences from these moves.

Public health relevance
PROJECT NARRATIVE Migration has important consequences for public health. These consequences can be stronger for involuntary migration, such as relocation resulting from climate change. This project investigates how climate influences internal migration in eight Sub-Saharan African countries. The impact of migration cuts across social and economic policies, development agendas, and social norms, all of which are known to affect public health. Future climate change is likely to redistribute populations in need of health services and might also undermine health status in migrant destinations.